Empowering Women for Postpartum Care in the Mississippi Delta

Maternal mortality and morbidity remain unacceptably high across the United States, and particularly in the Mississippi Delta, where women experience an elevated risk of loss of life and health. Evidence supports that engagement in healthcare across the pre- and postpartum continuum can reduce adverse maternal outcomes. However, barriers to engagement in maternal healthcare persist in the Mississippi Delta, despite many attempts to intervene. Poverty, transportation, lack of health insurance, poor health literacy, and limited availability of healthcare also contribute to health disparities. To improve access to care and quality of healthcare services, these well documented factors and barriers must be acknowledged and addressed in a comprehensive manner. In this research project, we propose a multisectoral patient-clinical linkage intervention to increase comprehension, trust, and engagement in postpartum healthcare among parents in the Mississippi Delta.
The intervention will directly address these documented factors and barriers to engagement in postpartum healthcare through (a) improving health literacy and communication skills among community health workers and licensed clinicians (focusing on skills, written text and oral communication, tasks and activities for services utilization, and the environment for provision of health services); (b) community health worker care coordination to facilitate pre- and postpartum visits; and (c) employing strategies to increase insurance utilization postpartum and defray the costs of attending care. These interconnected research activities aim to reduce barriers to healthcare engagement, thereby empowering postpartum women to seek, advocate for, and receive the healthcare they deserve. This research project will implement and evaluate the proposed intervention through the following aims: (1) refine and implement the community-based patient-clinical linkage intervention and evaluate its effectiveness in increasing maternal health engagement in medical care; (2) evaluate the effectiveness of the community-based patient-clinical linkage intervention in improving health literacy and increasing trust; and (3) evaluate the effectiveness of the community-based patient-clinical linkage intervention in improving reproductive autonomy among postpartum parents in the Mississippi Delta. By providing concrete support to access information and care, we will connect parents at high risk for adverse maternal outcomes to quality preventive services. Ultimately, this research project will support the overall mission of the JSU- Mississippi Delta Research Center of Excellence for Maternal Health to empower women through increased trust and health literacy while reducing maternal morbidity and mortality in partnership with the Mississippi Delta community.

Public health relevance
PUBLIC HEALTH RELEVANCE This proposal aims to establish the Jackson State University (JSU) - Mississippi Delta Research Center of Excellence for Maternal Health to address preventable maternal mortality, decrease severe maternal morbidity, and promote maternal health in partnership with the Mississippi Delta community. This research center will conduct two multi-layered research projects utilizing community health partners, inclusive of an extensive research training program for early-stage investigators, to address the factors that affect maternal outcomes. By establishing partnerships with the community in all parts of the process, we envision that this research center will overcome barriers to high-quality, relevant postpartum maternal care and ultimately improve maternal morbidity and mortality for women residing in the Mississippi Delta.